Endosymbiont mediated chitin catabolism in the tsetse fly gut impacts trypanosome transmission

The midgut of most arthropods is lined by a peritrophic matrix (PM) that is composed of a chitin backbone upon
which assemble a variety of glycosaminoglycans and proteins. The PM serves a defensive role within arthropods
by protecting their midgut epithelia from abrasive food particles, regulating the movement of ingested toxins, and
serving as a physical barrier against pathogen infection establishment. Some vector-borne protozoan pathogens,
including mosquito-transmitted Plasmodium and sand fly-transmitted Leishmania, secrete chitinases that can
degrade PM-associated chitin. However, tsetse fly-transmitted African trypanosomes do not produce chitinase,
and the mechanism(s) these parasites use to circumvent tsetse’s PM are poorly understood.
In addition to potentially being infected with African trypanosomes, all tsetse flies harbor a taxonomically
variable community of endosymbiotic bacteria. The success of trypanosome transmission through the tsetse
vector depends in part on physiological interactions between the fly and these bacteria. One of tsetse’s
endosymbionts, Sodalis glossinidius, exhibits a homogeneous distribution within all laboratory colonized flies
and a heterogeneous distribution within and between wild fly populations. Several independent field and
laboratory-based studies have repeatedly demonstrated a positive correlation between the presence and density
of Sodalis in tsetse’s midgut and the ability of trypanosomes to successfully establish an infection in the fly. The
mechanisms that underlie this correlation have never been determined. In this application our interdisciplinary
research team will address the hypothesis that a Sodalis secreted endochitinase degrades the chitinous
backbone of tsetse’s PM. We speculate that Sodalis-mediated degradation of PM-associated chitin facilitates
trypanosome infection establishment in two ways. First, this process would compromise the structural integrity
of the PM, thus making it easier for trypanosomes to cross. Second, chitin catabolism results in the production
of N-acetyl-D-glucosamine, which is a potent inhibitor of trypanocidal lectins. We propose to use Sodalis mutants
that cannot produce endochitinase to functionally characterize the tripartite relationship between the bacterium,
tsetse’s PM, and trypanosome infection establishment in the fly’s midgut. Additionally, we propose to use field
captured tsetse flies to determine if their Sodalis produce endochitinase that mediates the structural integrity of
their tsetse host’s PM. Completion of the experiments proposed in this application will increase our
understanding of the basic physiological mechanisms that mediated trypanosome transmission through the
tsetse vector and may have translational implications towards the development of novel disease control
strategies. Additionally, knowledge obtained herein will be applicable to other arthropod vector model systems
(e.g., mosquitoes, ticks, sandflies) that house midgut-associated bacteria and have a PM that pathogens must
cross in order to be transmitted to a new vertebrate host.

Public health relevance
Narrative This exploratory research will generate fundamental information necessary to better understand the functional basis of the tsetse fly-Sodalis symbiosis as it relates to trypanosome infection in the fly. We will determine whether a putative Sodalis endochitinase exhibits chitinolytic activity, and if this enzyme degrades the chitinous component of tsetse’s peritrophic matrix such that the structure becomes a less effective barrier against trypanosome infection establishment. Collectively, findings from this research will provide functional insight into the physiological mechanisms that mediate trypanosome infection establishment and transmission through the tsetse fly vector.